Role of Oculomotor Vermis Parallel Fibers in Saccades

[unreadable] DESCRIPTION (provided by applicant): Output from the cerebellum is critical to making accurate voluntary rapid eye movements, called saccades. Accurate saccades are essential to our clearly seeing the world around us because the high-resolution part of the eye, the fovea, is very small. To see clearly we must aim the fovea quickly and accurately at the things we want to see. Patients with damage to the eye movement part of the cerebellum cannot make accurate saccades and have a very difficult time seeing the world around them. [unreadable] [unreadable] The cerebellar output influencing the horizontal component of saccades consists of action potential bursts from neurons inside the cerebellum, the caudal fastigial nucleus (CFN). CFN cells on one side of the cerebellum exhibit action potential bursts early in saccades away from that side (contraversive saccades). These early bursts help accelerate contraversive saccades. CFN cells also burst later for saccades toward the side they are on (ipsiversive saccades). These bursts help decelerate ipsiversive saccades. [unreadable] [unreadable] The later decelerating, burst for ipsiversive saccades influences saccades much more than the early, accelerating burst does. It is also largely responsible for making saccades accurate. No signal going into the cerebellum resembles these late decelerating bursts so the cerebellum almost certainly produces them by changing the signals that it receives. [unreadable] [unreadable] We propose that the cerebellum generates late, decelerating, CFN bursts by delaying saccade-related signals that come from outside the cerebellum. It delays these signals by conducting them through the eye movement part of the cerebellum in axons called parallel fibers (p-fibers). If this is true, then interrupting p-fibers in the eye movement part of the cerebellum will abolish the late burst in CFN neurons. Saccades will not decelerate enough so they will overshoot their targets. The work proposed here will conclusively test this hypothesis by measuring saccades after we cut the p-fibers in the eye movement part of the cerebellum. [unreadable] [unreadable]